Admin Core

Administrative Core – Abstract
The Center for the Assessment of Tobacco Regulations (CAsToR) aims to provide a comprehensive approach
for estimating the population impacts of FDA regulations. Our integrative theme is to provide the CTP external
modeling capabilities to evaluate the potential health and behavioral impacts of individual and combined
regulations. The primary scientific domains of the Center are Impact Analysis, Behavior, and Health Effects.
The purpose of the Administrative Core is to provide and integrate scientific leadership, administrative support,
and fiscal management for the entire Center.